Baylor Research Education Program in Clinical Neurosciences

Baylor Research Education Program in Clinical Neurosciences
Abstract
Baylor College of Medicine has been the premier medical training program in Houston, TX for
over half a century. The primary neurological training programs include Neurosurgery,
Neurology, and Pediatric Neurology. These programs have always had a strong academic
tradition, and graduates have served as faculty at many leading medical schools, but historically
there was a decidedly clinical emphasis. Over a decade ago, a strategic decision was made to
focus on research and research education by capitalizing on the extraordinary scientific
resources at Baylor College of Medicine and affiliated institutions in the Texas Medical Center.
Many residency programs, including these three, were retooled to substantially enhance their
ability to train the next generation of academic neurologists and neurosurgeons. In 2009, the
BCM Department of Neurosurgery was awarded the predecessor NINDS R25 grant to support
resident research. Our successful renewals in 2014 and 2019 evidence the strength of clinical
neurosciences research at BCM that is available to support our trainees and propel them
towards independent careers as clinician-scientists. In this UE5 renewal, we expand the breadth
of the program to offer the same high-caliber training to residents in Neurology and Pediatric
Neurology and make these opportunities available to future trainees interested in neuroscience
research in related disciplines such Radiology, Anesthesiology, Pathology, and Emergency
Medicine. We will select outstanding residents who have the background, talent, and motivation
to become successful clinician-scientists, and then carefully integrate additional specialized
research education into their residency training and beyond. The UE5 program will mentor these
residents through the entire research process, from project conception to experimental design,
data analysis and interpretation, to publication of results, and finally to the development of an
effective plan for beginning a career as a physician-scientist. The mentorship established by this
program will continue beyond residency into fellowship and the early career stages. In addition
to carrying out a research project, residents selected for this research education program will be
trained in experimental design, scientific writing, oral presentation, and in the responsible
conduct of research. Furthermore, they will receive considerable oversight and career
counseling from a team of expert mentors with the intent of paving their way to success in
obtaining a mentored career development award and becoming productive, independent
physician-scientists.

Public health relevance
Baylor Research Education Program in Clinical Neurosciences Narrative The primary goal of this research education program is to provide residents in the clinical neurosciences with the opportunity to complete a cohesive, significant research project starting in their residency training. The program will mentor residents through the entire research process, from project conception to experimental design, data analysis and interpretation, to publication of results and finally to a mentored faculty position and ultimately to an independent research program. This hands-on approach is the most effective way to prepare the next generation of young clinician-scientists for a productive research career in the clinical neurosciences.